Cellular, molecular, and biochemical sciences training grant

Summary
The Cellular Molecular and Biochemical Sciences Program (CMBP) at Ohio State University (OSU) draws faculty
and trainees from four related molecular life sciences graduate programs: Microbiology, Molecular Cellular and
Developmental Biology, Molecular Genetics, and the Ohio State Biochemistry Program. The goal of the CMBP is to
create opportunities for student training not available through other programs on campus by providing: (1) a broader
range of rotation choices, (2) interdisciplinary monthly meeting seminars and symposia, (3) coursework that
includes an emphasis on the responsible conduct of research, scientific writing, rigor and reproducibility, and
training in quantitative skills, (4) career-advancing components including professional development workshops
specifically developed for this program, internship opportunities, and Individual Development Plans, and (5) faculty
mentor training to ensure a holistic and supportive advisory environment conducive to trainee growth and
development. CMBP is a rigorous program designed to attract top students to OSU, and the breadth and depth of
the training provided will position CMBP graduates to make significant contributions to biomedical research in
academia, government, and industry. In the past few years, sustained and significant institutional support has
facilitated interdisciplinary research and graduate training at OSU. The unique combination of opportunities offered
through the CMBP has already increased recruitment and retention of the very best graduate students, in particular
from underrepresented minorities (URM) and students with disabilities. Strong matching institutional support has
allowed us to exceed our goal of having one quarter of fellowships awarded to URM/disability/disadvantaged
students, with 40% of the trainees supported over the last 10 years being in one of these categories. The resources
requested in this proposal would allow us to build on initiatives developed over the last 10 years and continue to
further develop a graduate training experience that spans a broad range of topics and activities in the cellular,
molecular and biochemical sciences. Specifically, we are requesting funds to appoint eight students annually as
CMBP fellows with funding initially for a year, renewable for a second year based upon adequate progress.
Trainees will remain members of the CMBP after completion of their funding, thereby assuring their continued
mentoring, training and development as they move forward to diverse careers in the biomedical workforce.

Public health relevance
Project Narrative We seek support for the established graduate training program at Ohio State University (OSU) in Cellular, Molecular and Biochemical Sciences (CMBP). This program involves 39 faculty trainers from four related molecular life sciences graduate programs who represent the highest standards of teaching and research excellence at OSU. The CMBP provides unique opportunities for training a diverse cohort of students that integrates career-advancing components with excellence in scientific research, positioning graduates to make significant contributions to biomedical research in academia, government, and industry.